Developing a Feedback-Controlled Heated Vest to Address Thermoregulatory Dysfunction in Persons with Spinal Cord Injury

Persons with spinal cord injury (SCI), particularly [cervical injuries (tetraplegia]), are unable to effectively
regulate core body temperature (Tcore) due to interruption of motor, sensory, and sympathetic pathways.
Thus, control of distal extremity vasoconstriction (heat conservation) and shivering thermogenesis (heat
production) are impaired, and the ability to maintain a constant Tcore is compromised. Persons with tetraplegia
often report “feeling cold,” frequently present with subnormal Tcore (35-36.5°C), and are particularly vulnerable
to hypothermia (Tcore<35°C) and associated impairment in cognitive performance, even when exposed to
temperatures that are comfortable for able-bodied (AB) individuals. Cool seasonal temperatures have been
shown to have a greater adverse effect on personal comfort, activities of daily living (ADLs), and vital daily
activities in persons with tetraplegia than that of AB controls. Conversely, a minimal increase in Tcore from
subnormal to normothermia, secondary to ambient heat may improve cognitive performance. Interventions
addressing the tendency to poikilothermia and enhanced vulnerability to hypothermia in persons with
[tetraplegia] are limited. Therefore, exploration of safe and efficacious bioengineering solutions to address the
physiological, cognitive, and quality of life (QoL) issues associated with the routine exposure to cool
temperatures that persons with [tetraplegia] often encounter is warranted.
The goals of this pilot study in persons with [tetraplegia] are: 1) to study the safety and tolerability of a
feedback-controlled heated vest and then 2) to study the efficacy of this heated vest to minimize the expected
decline in Tcore and associated deterioration of cognitive performance during 2 hours of cool exposure.
This single-group (persons with [tetraplegia]), two-condition (heated vest, non-heated vest) prospective study is
being proposed to compare the physiological and cognitive responses to controlled cool exposure (18°C) with
a prototype heated vest vs. a non-heated vest (control condition). [Eight] subjects with [tetraplegia (C3-T1], AIS
A and B) and [eight] AB controls will be recruited for study participation. AB subjects will be observed to ensure
the safety of the vest, which will be accomplished by determining the temperatures of the vest and subjective
thermal sensation of less than “hot” during a cool condition that will be identical to that to which subjects with
SCI will be exposed. Subjects with [tetraplegia] will test the efficacy of the heated vest, i.e. preventing the
expected decline in Tcore and cognitive performance and increased thermal comfort.
Primary Specific Aim: In a cool thermal chamber (18°C), AB controls will wear the heated vest at maximal
setting for 120 minutes in the seated position to determine (1) maximum temperatures of all areas of the
interior (user’s side) of the heated vest and (2) subjective comfort of the heated vest (safety testing).
Primary Hypotheses: (1) 100% of the interior surface of the vest will have temperatures ≤38°C. (2) 100% of
AB controls will report a thermal sensation of only “warm” and not “hot”. (3) 100% of AB controls will not report
any areas of concentrated heat, e.g. “hot” spots (Zhang 9-point Thermal Sensation Scale).
Secondary Specific Aim: During exposure to a cool environment (18°C) for up to 120 minutes in the seated
position, persons with [tetraplegia] will wear the heated vest to determine (1) change in Tcore, (2) change in
cognitive performance, and (3) change in thermal comfort (efficacy testing).
Secondary Hypotheses: In persons with [tetraplegia] wearing the heated vest compared to the same persons
wearing the non-heated vest, it’s expected that (1) 30% of the subjects will have a decline of at least 0.5°C in
Tcore compared with 80% in the control condition, (2) 30% of the subjects will demonstrate a decline of at least
1 T-score in at least one of the following measures: Interference of Stroop Color and Word test, Digit Span of
Wechsler Adult Intelligence Scale-Fourth Edition, compared with 80% in the control condition, and (3) a greater
percentage of subjects reporting increased thermal comfort (Zhang 6-point Comfort Scale).

Public health relevance
Persons with higher levels of spinal cord injury (above the [2nd thoracic vertebrae; tetraplegia]) are unable to maintain normal core body temperature (Tcore) when exposed to cool environments. Even with limited exposure to cool temperatures in persons with [tetraplegia], Tcore may approach hypothermic values and impair cognitive performance. Conversely, an increase in Tcore from subnormal to normal range may improve cognitive performance. Prior work has shown that cool seasonal temperatures have an adverse effect on personal comfort and the ability to perform vital daily activities of self-care in persons with [tetraplegia]. Interventions that address the vulnerability to hypothermia are limited. A self-regulating heated vest designed specifically for persons with [tetraplegia] is a novel and promising strategy to address this problem. By more effectively maintaining Tcore, the vest can decrease the adverse impact of cool temperatures on comfort, quality of life, and performance of vital daily tasks for Veterans with [tetraplegia] during the cooler seasons.